Glutamatergic mechanisms of psychosis and target engagement

PROJECT SUMMARY/ABSTRACT:
Schizophrenia (Sz) is associated with psychotic symptoms that remain partially or fully refractory to standard
antipsychotic medications for most patients. All marketed antipsychotics primarily work through blocking
dopamine D2 receptors. Despite robust effectiveness in preclinical models, alternative, glutamatergic
approaches for treatment development have not yet led to FDA approved medications. A major barrier to
effective glutamatergic treatment development is the absence of validated measures for functional target
engagement that can identify effective compounds and guide dose selection. The present project seeks to refine
ketamine-induced pharmacoBOLD (phBOLD) as target engagement biomarker for development of
metabotropic glutamate (mGluR2/3) agonists. The combination of aims will permit future studies using phBOLD
to identify potential candidates for glutamate-based interventions, permit target engagement studies within Sz
and explore the mechanisms of dopamine and glutamate in psychosis.
As part of the recently completed NIMH multicenter FAST-PS initiative, we have evaluated ketamine-induced
phBOLD in healthy volunteers (HV). In an initial HV study, we demonstrated that ketamine induces a robust,
highly significant increase in phBOLD response. More recently, using this assay we have demonstrated that the
dose of an mGluR2/3 agonist (POMA) used in the prior clinical studies (80 mg) did not lead to significant
inhibition of ketamine-induced phBOLD or symptomatic response in HV, suggesting that prior negative clinical
results may have resulted from inadequate dosing. By contrast, at doses ~4x higher than those used in the
negative clinical trials, evidence of behavioral target engagement was observed, underscoring the need for in
vivo clinical biomarkers. In parallel studies of of a more recently developed mGluR2/3 agonist (TS-134), we
demonstrated showed evidence of both behavioral ( and phBOLD pre-post target engagement. In addition, TS-
134 suppressed ketamine induced phBOLD known to be integral for dopaminergic function.
Aims of the present project are as follows. Under Aim 1, we will titrate the ketamine dose downward in HV in
order to identify doses that produce reduced psychotomimetic effects, but nevertheless sufficiently robust
(d=1.5) phBOLD effects to permit detection of mGluR2/3 agonist effect. We will then evaluate the degree to
which still-lower doses of ketamine nevertheless produce sufficient phBOLD response (d=1.5) to enable target
engagement testing in Sz patients. Finally, we will evaluate the relative sensitivity of different doses of ketamine
to TS-134 in HV in order to determine optimal target effect sizes for future target engagement studies in Sz. In
parallel, we evaluate the sensitivity of the dopamine system to NMDAR antagonism, along with the relationship
of ketamine phBOLD, 1H MRS and a proxy measure of dopamine synthesis capacity using neuromelanin.

Public health relevance
PROJECT NARRATIVE Several glutamate-targeted medications have failed in pivotal clinical trials despite robust effectiveness in preclinical models. In the present project, we propose to further develop ketamine biomarkers glutamate- based treatments and explore glutamate and dopamine mechanisms of schizophrenia using brain imaging.